MULTIFREQUENCY EPR CHARACTERIZATION OF CR IONS IN LASER CRYSTALS

Ytrium Orthoaluminates (YA103) are technologically important crystals for laser applications. Properties of these materials can be manipulated by doping with different ions, and Cr(3+) in particular. Here we apply EPR at X-, Q-, and W-frequency to fully characterize Cr(3+) ion and to derive accurate zero-field-splitting (ZFS) parameters.